Behavioral, Lifestyle, and Cultural Risk Factors for Bone Quality and Osteoporosis in the PROSPECT Cohort

PROJECT SUMMARY
Data on osteoporosis (OP) among adults living in the US territory of Puerto Rico (PR) is limited. However,
evidence suggests that adults in PR may be at high risk of OP (12% for lumbar spine, 8.7% for femoral neck),
although the few studies that exist are small, outdated, or rely on self-report. This is supported by data in
Puerto Rican (PR) adults from the US mainland showing increased risk for OP compared to non-Hispanic
White adults. OP is a serious musculoskeletal disease increasing risk of fragility fracture, morbidity, and
mortality. Diet is a known modifiable preventative factor for OP, but evidence for recommendations remains
unclear. Psychological stress has been proposed as a novel risk factor for bone health through dysregulation
of the hypothalamic-pituitary adrenal and sympathomedullary axes, but most evidence is from animal studies.
This relationship may be further modified by diet, which is related to stress and OP. Trabecular bone score
(TBS), a low-cost indicator of bone quality, has not been examined in adults in PR. Adults living in PR may be
susceptible to poor bone health, as this population has low dietary quality and high psychosocial stressors due
to social and environmental inequities compounded by climate-related disasters. A Dietary Approaches to Stop
Hypertension (DASH) diet has been shown to be most protective against OP in PR adults from the US
mainland. Adults in PR consume both healthy (legumes, dairy, locally sourced fruit/vegetables, seafood) and
unhealthy foods (sugary beverages, refined grains, French fries, SPAM), which may differ from PR diets on the
US mainland. Developing culturally relevant, effective prevention strategies for OP has been hindered by a
major gap in PR: the lack of rigorously collected data on OP and risk factors. Thus, our central hypothesis is
that OP is prevalent and that psychophysiological stress and dietary factors are related to bone health among
adults in PR. The proposed ancillary study will build on the Puerto Rico Osteoporosis Study of Psychosocial,
Environmental and Chronic Disease Trends (PROSPECT), an ongoing investigation of risk factors for CVD in
adults 30-75 y in PR. Adults (n=1000) aged > 45 y, who complete their 4-y PROSPECT visit, will be invited to
complete additional measures including bone mineral density (BMD), TBS, and questionnaires. Our project
aims to: 1) quantify BMD and TBS in PROSPECT, and to compare prevalence of OP to national data and data
for US mainland PR adults; 2) assess dietary intake and biomarkers in relation to bone outcomes; and 3)
quantify measures of psychophysiological stress and assess their relationships to bone outcomes in
PROSPECT. This ancillary study is time sensitive, as PROSPECT will start its 4-y follow up in May 2024,
providing a unique opportunity to add OP as an outcome, capitalizing on existing data from the parent study.
The proposed study will provide timely data to inform clinical and public health efforts to prevent bone loss and
OP for the population of PR. This study will answer new lines of inquiry on the interconnections between diet,
stress, and bone outcomes that will serve as a foundation for populations with high prevalence of OP.

Public health relevance
PROJECT NARRATIVE Limited data exist on osteoporosis among adults living in Puerto Rico (PR), and the few studies that are available are small, outdated, or rely on self-report. Psychological stress, which has been proposed as a novel risk factor for bone health, and dietary quality may be important risk factors for bone health among adults living in PR, as most have reported low dietary quality and moderate to high perceived stress. However, there is insufficient evidence to inform recommendations and findings from the proposed study will guide future public health strategies that are needed to address risk factors for osteoporosis in this population.